Dynamic Regulation of Tuning in Adult Auditory Cortex

DESCRIPTION (provided by applicant): Learning and memory are absolutely essential to hearing. In their absence, comprehension would be impossible because no auditory information could be acquired or stored, and the recognition of previously heard sounds would be impossible. The long-term objectives of this research project are to discover the neural mechanisms that enable sounds to acquire meaning. The primary auditory cortex (A1) has been identified as a site for the acquisition and storage of auditory information. In general, encoding of behaviorally relevant sounds is strengthened as part of an overall functional remodeling of acoustic representation. For example, when a tone becomes a signal for rewarding or aversive stimuli, frequency tuning shifts toward or to the signal frequency, strengthening its encoding while weakening that of other frequencies. Tuning shifts can increase the area of signal representation in A1, and the amount of gain is directly proportional to both the cue's level of acquired importance and its memory strength. Such representational plasticity (RP) appears to be a substrate of auditory memory because it has the same attributes as memory itself. Engagement of mAChR's in A1 directly or by pairing tone with stimulation of the cholinergic nucleus basalis (NBstm) is sufficient to (a) produce RP, (b) actually implant specific behavioral auditory memory, and (c) increase neural synchrony (NSync). Further, increased synchrony predicts both RP in A1 and auditory memory. Thus, sounds may gain meaning via increased neural synchrony, which gives them greater effectiveness in communicating with target structures and strengthening their own representations. The specific aims of this project are to determine if increasing NSynch (gamma band oscillations and unit co-variances) during signal presentation can strengthen and increase the specificity of auditory memory, and/or enhance RP. Rats will be trained in auditory fear and reward tasks while a signal tone's induced neural synchronization is boosted via increasing loudness or brief concurrent NBstm. Studies will determine if increasing NSync can enhance memory strength and specificity, using custom designed training protocols that produce a modest level of RP and memory. If these experiments uncover neural synchrony as a mechanism sufficient to strengthen and/or produce specific auditory memory, then this project will have opened a pathway for remediation of auditory comprehension disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: Many problems in hearing are auditory processing disorders that impair the ability to properly grasp the meaning of language and other sounds. The goal of this research project is to discover the brain mechanisms that provide for comprehension of sound. Once these are known, effective treatments can be designed and used to treat those disorders.